Regulation of heterotrimeric G protein signaling by subunit phosphorylation

Project Summary
Heterotrimeric guanine nucleotide-binding (G) proteins composed of Gα, Gβ, and Gγ subunits function as
molecular switches in signal transduction. Human G protein pathways are targets of over 30% of clinical drugs
and their mutation causes genetic disease, developmental abnormalities, and altered infectious disease
susceptibility. While humans have 16 Gα, 5 Gβ, and 12 Gγ genes, the model plant, Arabidopsis thaliana, has
many fewer -- only one canonical Gα (GPA1), one Gβ (AGB1), and three Gγ (AGG1, AGG2 and AGG3) genes.
Yet plant G proteins, as in humans, regulate a multiplicity of pathways. Arabidopsis G protein mutants show
developmental defects, defects in pathogen defense, and defects in responses to environmental stresses.
While Arabidopsis has only one protein (GCR1) with sequence and structural similarity to the 800+ metazoan
GPCRs, Arabidopsis has ~600 receptor-like-kinases (RLKs), which form a monophyletic group with Pelle
kinases of metazoans. Mass spectrometric analyses in the PI's lab have revealed multiple RLKs present in
GPA1 and AGB1 immunoprecipitates, consistent with new genetic evidence of RLK/G protein interaction and
confirmed by our kinase assays showing direct GPA1 phosphorylation by RLKs. Phosphoproteomics identifies
G protein subunit phosphorylation at conserved sites in plant and metazoan G protein subunits. The
overarching hypothesis of the proposed research is that phosphorylation of G protein subunits is an
evolutionarily conserved regulatory mechanism that confers specificity to G protein signaling. Three explicit
hypotheses are: 1) phosphorylation of G protein subunits controls G protein guanine nucleotide exchange,
GTPase activity and heterotrimer association; 2) ligand-activated kinases (RLKs in plants) are GPCRs at the
apex of phospho-controlled G protein signaling networks, and; 3) Gα and Gβγ subunit phosphorylation confers
specificity to G protein subunit interaction with downstream partners (effectors). These hypotheses will be
tested in the Arabidopsis system by, respectively: 1) biochemical assays of the G protein cycle and protein-
protein interactions within the heterotrimer; 2) genetic epistasis analysis between G protein subunits and
implicated RLKs, phosphoproteomic analyses of G protein subunits following RLK ligand stimulation and in rlk
null lines, and in vitro phosphorylation assays; 3) phenotyping of G protein subunit null mutants complemented
with phosphomimic and phosphonull G protein subunits, identification of phosphorylation-dependent subunit-
effector interactions by coimmunoprecipitation and protein-protein interaction assays, and targeted tests of
effector competition for G protein subunits. Arabidopsis is ideal to address these issues in a systematic and
comprehensive manner, as it provides a limited number of G protein subunits, ease of manipulation, a plethora
of genetic tools, and an array of whole-organism and single-cell G protein phenotypes. Completion of these
goals will reveal new mechanisms of G protein modulation, amenable for manipulation and drug targeting to
meet the major challenge of pathway-specific control of G protein signaling for improvement of human health.

Public health relevance
Project Narrative The proposed research will employ a highly tractable system to provide a comprehensive understanding of the regulation of heterotrimeric G protein signaling by subunit phosphorylation, revealing specific post-translational modifications that strengthen or impair the G protein cycle and effector interactions. Many human infectious and genetic diseases disrupt G protein pathways, which are a fundamental eukaryotic signaling mechanism. Results obtained will identify new G protein conformations for drug discovery and facilitate the development of targeted interventions that repair the dysregulated aspects of G protein signaling caused by disease, without impairing other G protein functions.